Epidemiology of Diabetes Interventions and Complications (EDIC) Study

Project Summary
The Diabetes Control and Complications Trial (DCCT,1983-1993) compared intensive therapy aimed at near-normal
glycemia versus conventional therapy with no specific glucose targets in 1441 subjects with type 1 diabetes (T1DM) over
a mean follow-up of 6.5 years. Intensive therapy reduced the risks of retinopathy, nephropathy, and neuropathy by 35-76%.
The level of glycemia was the primary determinant of complications. We also described the adverse effects of intensive
therapy; assessed its effects on cardiovascular disease (CVD) risk factors, neurocognition and quality of life; and projected
the lifetime health-economic impact. After the primary DCCT results were reported in 1993, intensive therapy aiming for a
HbA1c <7% was adopted world-wide as standard-of-care for T1DM.
The Epidemiology of Diabetes Interventions and Complications (EDIC, 1994-present) is the observational follow-up
study of the DCCT cohort. Micro- and cardio-vascular complications and a wide range of established and putative risk
factors, including genetic and epigenetic factors, have been measured with standardized methods, carefully documented and
events adjudicated. EDIC has notably shown that the early beneficial effects of intensive versus conventional therapy on
complications persisted for ~15 years despite the convergence of HbA1c levels in the two groups during EDIC, a novel
concept termed metabolic memory. Prior intensive therapy was also shown to reduce substantially the risk of CVD events
and mortality.
The overarching goals for the next 5 years (2022-27) will be to study the occurrence and identify potentially modifiable
risk factors of the more advanced microvascular and cardiovascular complications and physical and cognitive dysfunction
that are occurring with increasing diabetes duration and age. With increasing longevity, the increased adiposity that has
affected patients with T1DM, including EDIC participants, has potential adverse consequences. Thus, the impact of diabetes
duration, aging and adiposity on morbidities and their underlying risk factors will be studied. The results will guide treatment
priorities as T1DM patients age.
The specific aims for 2022-2027 are to: 1) determine the incidence of advanced microvascular complications,
investigate the order of their development and pattern of co-development, and identify glycemic and non-glycemic risk
factors; 2) quantify impairment in functional and myocardial performance that presages heart failure (HF) and identify the
risk factors for impairment in T1DM; 3) determine the prevalence of Non-Alcoholic Fatty Liver Disease (NAFLD) and
steatohepatitis-associated fibrosis (NASH) and symptoms suggestive of obstructive sleep apnea (OSA) in this increasingly
overweight/obese T1DM study population and identify precedent risk factors and mechanisms; and 4) continue the
longitudinal assessment of aging-sensitive morbidities such as cognitive and physical dysfunction, frailty, and their risk
factors and their aggregate impact on quality of life, ability to self-manage T1DM, and health economic outcomes.

Public health relevance
Project Narrative Type 1 diabetes mellitus (T1DM) affects over 1,800,000 Americans and Canadians who are at risk of developing microvascular (eye, nerve, and kidney) and cardiovascular complications that are a major cause of morbidity, mortality, and health care cost. Based on advances in diabetes care, largely resulting from the findings of the DCCT, patients with T1DM now live longer lives and are experiencing the increasing body weight that is prevalent in the non-diabetic and type 2 diabetes populations. EDIC will turn its attention to understanding the effects of very long T1DM duration in our aging and increasingly overweight and obese population, which reflects T1DM in the U.S. and Canada, and to exploring potentially modifiable risk factors for advanced microvascular complications, cardiac disease including the early stages of heart failure, fatty liver disease and sleep apnea, and cognitive and physical dysfunction.